CRISPR RNA-guided recognition of invading RNA activates a multipronged cell death response

PROJECT SUMMARY
CRISPRs (Clustered, Regularly, Interspersed, Palindromic Repeats) and CRISPR-associated proteins (Cas)
are essential components of adaptive immune systems in bacteria and archaea that provide sequence-specific
protection from viruses and other genetic parasites. CRISPR systems are phylogenetically and functionally
diverse. Most of the work on CRISPR systems has focused on a subset of systems that function as RNA-
guided endonucleases that exclusively bind and cleave double-stranded DNA (dsDNA). In all CRISPR
subtypes, this RNA guide is derived from the CRISPR loci transcripts and serves as a genetic memory of past
infections. The work in this application focuses on determining the structure and function of a unique type III
CRISPR system that includes Cas genes that contain domain fusions bearing strong homology to known toxins
(HEPN and RelE) and an antitoxin (MntA). Unlike most CRISPR systems, that target DNA, type III CRISPR
systems are unique in their utilization of multi-subunit ribonucleoprotein complexes to bind and destroy RNA
that is complementary to the CRISPR-RNA guide. In addition to targeting RNA, type III CRISPR systems
encode a specialized surveillance complex subunit called Cas10. Target recognition by type III triggers
polymerase-cyclase activity in the palm domain of the Cas10 subunit which amplifies the immune response by
selectively converting ≈4,000 ATP molecules into cyclic oligoadenylates that function as immune signaling
molecules. Using computational methods, the Wiedenheft lab has recently identified a unique subclass of type
III-B CRISPRs distributed across three phyla. These type III-B systems have co-opted elements of toxin-
antitoxin systems and the immune cassette includes an additional toxin that I predict is regulated by cyclic
oligoadenylate signaling. I hypothesize that these type III-B CRISPR-toxin-antitoxin defense systems rely
on CRISPR RNA-guided recognition of invading RNA to activate a multipronged cell death response. In
Aim 1, I will use cryo-electron microscopy to determine structures of the type III-B surveillance complexes in
various states of activation. These structures will provide critical mechanistic insight that explains how different
elements of the immune response are regulated by the effector complex. In Aim2, I will determine the
mechanisms by which specialized toxins stall viral infections via a CRISPR-controlled collapse of translation.
Collectively, these experiments and the associated training objectives outlined in this application will clarify
CRISPR-mediated mechanisms that regulate cell death in response to viral infection.

Public health relevance
PROJECT NARRATIVE CRISPR systems are diverse, RNA-guided, adaptive immune systems that provide sequence-specific defense against invading nucleic acids. In this fellowship application, I present specific experimental aims which are linked to training objectives that will provide critical mechanistic insight towards the biological function of a unique class of type III-B CRISPR systems physically linked to elements of toxin-antitoxin systems. Completion of the specific aims and training objectives in this proposal will advance my training in biochemistry and structural biology, while also providing new mechanistic insights that clarify how CRISPR systems limit viral spread through a population by triggering cell death through a multipronged attack on translation.